Expanding Multilevel Multicomponent Mentorship in Kidney Disease Research

Kidney disease affects nearly one in three adults worldwide and is associated with significant morbidity and
mortality. Throughout the last three decades there has been tremendous progress in understanding kidney
disease mechanisms that have led recently to new therapies including healthcare delivery strategies to
enhance delivery of health information and promote successful self-care, however quality of life as well as
survival remains poor especially for those living with advanced kidney disease including kidney failure.
Importantly the NIH/NIDDK has invested in ensuring that patient partners are integral to the process of
prioritizing as well as carrying out research. Similarly, NIH/NIDDK is further investing in ensuring the academic
research workforce is also diverse and representative. This is a critical objective across the spectrum of kidney
disease research including basic science, clinical and translational, and policy research. Dr. Cavanaugh is a
well recognized expert in kidney disease clinical trials, health literacy and its implications, formative research to
elucidate and integrate stakeholder perspectives into research and community engagement. Her objective is
to use the support of the K26 NIDDK Investigator Award to Support Mentoring of Early Career Researchers
from Diverse Backgrounds to focus on training the next generation of scientists to bring transformative
advancements in kidney disease research. The candidate’s immediate and long-term career objectives to be a
leader in research faculty development are directly in line with the goals of the NIH K26 award, to provide
support for protected time for awardees to devote to mentoring training and culturally-sensitive mentoring for
post-doctoral students. Specifically, this award will allow her to focus on the development of a multi-level
mentoring program to facilitate the career development of emerging early investigators. This award will provide
protected time for the candidate to devote specifically to executing rigorous research, serving as a primary,
collaborative, advocacy and network mentor, and to developing mentoring skills in research. Her objective is to
recruit and mentor post-doctoral fellows and junior faculty for successful clinical research careers in kidney
disease and to support the career advancement of her current trainees. She will accomplish this objective by
leveraging her research program resources as well as the robust institutional, regional and national resources.
The aims include (a) continued impactful research to expand opportunities for mentees; (b) development and
deployment of a novel culturally tailored psychological and instrumental advocacy kidney disease research
mentor program; (c) acquisition of mentoring skills training informed by an expert advisory committee; and (d)
execution of recruitment programs to identify and engage mentees from diverse backgrounds. Completion of
these aims will enhance the career advancement of kidney disease scientists from diverse backgrounds to
diversify and grow the future workforce of faculty dedicated to understanding and eliminating kidney disease.

Public health relevance
This award will provide protected time for Dr. Kerri Cavanaugh to devote specifically to developing skills and delivering mentoring in kidney disease research. Her objective is to recruit and mentor post-doctoral students as a primary mentor, and to serve as an advocacy/network mentor for pre- and post-doctoral trainees including those in graduate degree programs as well as emerging physician scientists including fellows and junior faculty, for successful research careers in kidney disease, and to support the career advancement of her current trainees. The proposal here will build on her developing skills as a mentor through dedicated training to ultimately deliver and lead multicomponent strategies to meet the needs of diverse students by leveraging her research program, aligned current leadership roles and the abundant local, regional and national resources.